Enrichment Program

The mission of the HDDC Enrichment Program is to facilitate advances in digestive disease-related research
by organizing events that promote exchange of ideas and knowledge among HDDC Members and the Boston
research community at large. The Program fosters the development of young investigators and the productivity
of established investigators whose interests are consistent with the Theme of the Center. By serving as the
intellectual crossroads for this research community, the HDDC Enrichment Program seeks to catalyze new
research collaborations and multidisciplinary projects, and to attract talented investigators from other fields into
research on the digestive tract in health and disease.
Specific Aims of the Enrichment Program are:
Specific Aim 1: To organize monthly seminars focused on diverse research themes relevant to digestive
diseases research, with the goal of enhancing knowledge and forging connections among investigators in
digestive disease research.
Specific Aim 2: To organize annual half-day symposia and full-day conferences in venues that feature new
ideas and facilitate scientific and social interactions and new collaborations among HDDC members, as well as
non-members whose research is potentially applicable to the digestive tract.
Specific Aim 3: To contribute to the professional training of young investigators by providing Workshops focused
on public speaking, grant writing and career development, and presenting at our annual Pilot Feasibility Program
Retreat.
The Enrichment Program continues to have a significant impact on the careers of young investigators in the
digestive diseases, to catalyze collaborations among HDDC Members, and to raise awareness of digestive
diseases research in the Boston scientific community.
!